Understanding Long-term Outcomes of Living Kidney Donors using Real-World Evidence from National EHR Data

Project Summary/Abstract
We will conduct a detailed analysis of the long-term health outcomes of living kidney donors (LKDs) utilizing
the comprehensive Cosmos dataset, which includes electronic health records (EHR) from over 245 million
individuals, among them 90,000 LKDs. Our goal is to understand how reduced kidney function after donation
impacts the health of LKDs compared to the general population. We aim to develop new clinical practices and
care guidelines specifically for LKDs, addressing this critical gap in care. We will examine the natural history of
kidney function, albuminuria, and systolic blood pressure (SBP) in LKDs, adjusting for variables such as age,
sex, and medication use to accurately model these health indicators, thus providing an in-depth view of the
health trajectory of LKDs following their donation. Furthermore, we will validate and possibly recalibrate the
CKD-PC and PREVENT equations within our LKD cohort. The CKD-PC (Chronic Kidney Disease Prognosis
Consortium) equations are used to predict renal outcomes based on factors such as age, sex, GFR, and
albuminuria levels, originally validated in the general CKD population. The PREVENT equations are used to
predict cardiovascular outcomes by integrating kidney function measures and have informed AHA guidelines
on statin use for persons with CKD. We will adjust these well-established equations to more accurately reflect
the unique post-donation physiological changes that LKDs experience, which will improve their utility in
predicting risks such as cardiovascular diseases and end-stage kidney disease for this specific population. In
addition, we plan to develop LKD-specific adaptations of the KFRE (Kidney Failure Risk Equation) predictive
models. KFRE is used to estimate the risk of progression to kidney failure based on clinical inputs, including
kidney function measures. We will integrate LKD status into the models, modifying parameters to cater
specifically to the nuances of kidney donor profiles to enable more precise and individualized risk assessments
for LKDs, which could improve post-donation care and monitoring. The culmination of our project will be a
virtual consensus conference, where we will engage with key stakeholders from major nephrology and
transplantation organizations. At this conference, we will present our research findings, discuss potential
updates to clinical practice guidelines for LKDs, and strategize on the most effective methods to disseminate
our research outcomes to healthcare providers and the broader LKD community. By leveraging the largest
national EHR data, which includes detailed information on over 90,000 racially representative kidney donors,
we strive to enhance medical care for LKDs. We aim to equip healthcare providers with tools and knowledge to
manage LKDs' health trajectories effectively, ensuring better outcomes for those who've altruistically donated
kidneys. We anticipate establishing a new standard of care for living kidney donors across their lifespan.

Public health relevance
Project Narrative This research project aims to deepen our understanding of the long-term health impacts of donating a kidney. By studying detailed medical records data from over 90,000 living kidney donors, we will develop, for the first time, health monitoring tools and tailored medical guidelines for living kidney donors. Our work will help improve the health outcomes of living kidney donors, provide tailored care, and reduce their risks of kidney disease, cardiovascular disease, and other associated conditions.